Enhancing Structural Competency in School-Based Health Centers to Address LGBTQ+ Adolescent Health Equity

Project Summary
School-based health centers (SBHCs) are at the frontlines of healthcare delivery and prevention services for
young patients across the United States. SBHCs provide vital services to school-aged youth, including
behavioral, sexual, and reproductive healthcare, often regardless of patients' insurance status or ability to pay.
Young patients who are gender or sexual minority (GSM) are far more likely to suffer from adverse health
outcomes than their cisgender and heterosexual peers. Structural or societal-based factors (e.g., stigma,
discrimination, low awareness of and insensitivity towards their health concerns) contribute to greater unmet
needs and poorer quality of care for GSM youth. Structural competency addresses the upstream factors (social
determinants of health, inadequate and fragmented treatment, inequities in care) that affect GSM students.
Enhancing structural competency within SBHCs will improve the care received by GSM students and, therefore,
their health. Emerging structural competency frameworks call for the cultivation of awareness and capacities in
SBHCs to modify organizational service delivery environments, including provider and staff knowledge and
behaviors, to influence wellbeing within this socially marginalized adolescent population. Nationally recognized
recommendations or guidelines for nurturing structural competency include (1) adoption, dissemination, and
enforcement of GSM supportive policies and procedures; (2) creation of welcoming physical environments for
GSM patients; (3) systematic documentation and use of sexual orientation and gender identity (SOGI)
information to inform and improve clinical services; (4) ongoing training for all employees in best practices for
interacting with GSM patients; and (5) clinical workforce development to encourage delivery of high-quality
services to GSM patients. This community-engaged implementation science study is scaffolded by school- and
SBHC-based research conducted in the rural, economically challenged, and culturally rich state of New Mexico.
This research provides a solid foundation for employing implementation science approaches to facilitate and
evaluate the adoption of these guidelines using the Dynamic Adaptation Process (DAP), a multifaceted
implementation strategy. We will conduct mixed-method readiness assessments to determine inner- and outer-
context determinants for implementing structurally competent changes in SBHCs; use a stepped-wedge trial
design to examine how DAP-enabled implementation impacts the adoption and effect of structurally competent
changes on SBHC, student (patient), and implementation outcomes; and assess the role of key inner- and outer-
context determinants, bridging factors, and associated mediators and moderators influencing implementation
processes and improved outcomes for GSM students. These outcomes include reduced barriers to care and
greater satisfaction and engagement in care. This study represents a key steppingstone to achieving our long-
term goal of high-quality care and decreased health and behavioral health disparities for GSM youth.

Public health relevance
Project Narrative Enhancing health and healthcare for gender and sexual minority (GSM) youth in the U.S. is a national public health priority. School-based health centers (SBHCs) are well-positioned to address disparities related to health and healthcare by providing structurally competent services to GSM youth. Our community-engaged study uses replicable approaches in implementation science to enable SBHCs to adopt new practices to make services structurally competent for GSM youth impacted by inequities in healthcare and, thus, health.